Statistical Methods for Large Scale Microbiome Studies of Cardiovascular Disease Risk

PROJECT SUMMARY
Cardiovascular diseases (CVD) are the leading cause of death globally, affecting nearly half of all adults in the
United States and responsible for a quarter of all deaths each year, with rates continuing to rise. The
microbiome offers a unique paradigm for investigating and eventually mitigating the global burden of CVD.
Aided by high-throughput sequencing technology, microbiome profiling studies have found bacterial
communities to be related to CVD risk factors, including hypertension and systolic blood pressure. This
knowledge is invaluable both from the perspective of better understanding etiology and from the perspective of
therapeutic development, as the microbiome is inherently modifiable. However, although many studies have
demonstrated possible relationships, the specific bacterial taxa associated with CVD risk factors, as well as the
manner in which they are related, are poorly understood. Recently, large scale microbiome profiling studies of
hundreds to thousands of individuals have been conducted within existing, on-going cohort studies. These
studies offer a unique opportunity to achieve more thorough investigation of the impact of microbiomes on CVD
risk factors. Unfortunately, the statistical and computational approaches for analyzing these studies are
lacking. This proposal aims to fill critical gaps in the methodological literature by addressing four major areas.
Specifically, we aim to develop comprehensive suite of statistical tools for (1) addressing batch effects in
microbiome studies – increasingly problematic as studies get bigger; (2) improved identification of individual
taxa associated with CVD risk factors; (3) conducting mediation analysis and understanding the relative role of
microbiota and exposures on risk factors; and (4) assessing the role of the microbiota as an effect modifier.
These approaches are all based on rigorous prior data emphasizing the importance of the problems as well as
the limitations or absence of existing strategies. Our work is motivated by and will directly enable analyses in
three of the largest, and richest microbiome profiling studies around: few studies have the combination of
sample size and richness of covariates as the CARDIA, MEC, and SOL microbiome studies. Consequently, our
methods have the potential for accelerating understanding of the role of microbes in CVD and facilitate
development of therapies and strategies for stemming the rising CVD epidemic.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease affects nearly half of all adults in the United States and is responsible for a quarter of all deaths annually, with rates rising. Within the context of three of the largest and richest microbiome profiling studies, this proposal seeks to develop statistical and computational approaches for enabling a more robust and sophisticated understanding of how microbes are related to cardiovascular disease risk factors. This information represents an imperative point of investigation both for possibly improving etiology and for possible development of therapies, particularly as the microbiome is modifiable.